Understanding disparities in cardiovascular toxicity among breast cancer survivors in Arkansas

PROJECT SUMMARY
Cardiovascular disease (CVD) is a rapidly growing public health concern for female breast cancer (BC)
survivors. This is due, in part, to cardiovascular (CV) toxicities from common cancer therapies that are
associated with CVD. CV toxicities are more common among marginalized racial and ethnic groups. They are
also more common among individuals at lower levels of socioeconomic and insurance status, as well as those
living in disadvantaged neighborhoods or rural areas. Yet, the complex role of these factors—social
determinants of health (SDOH)—in CV toxicity disparities among BC survivors is unknown, and few studies
have considered the intersections among race, ethnicity, and SDOH. Given the known relationship between
SDOH and cardiometabolic dysfunction, disparities in SDOH may contribute to CV toxicities among BC
survivors through increased risk of comorbid cardiometabolic dysfunction. Therefore, to improve the CV health
of BC survivors, it is critical to examine CV toxicity disparities in the context of cardiometabolic dysfunction. To
address this issue, the following specific aims will be completed:
1) Identify the extent of disparities in incident CV toxicity among BC survivors in Arkansas based on
race, ethnicity, neighborhood socioeconomic status, and geography.
2) Develop a predictive algorithm for risk stratification in BC survivors at high risk for CV toxicity using
machine learning approaches that incorporate race, ethnicity, and SDOH.
Data collected from 2013–2019 in the Arkansas All-Payer Claims Database (APCD) linked to the Cancer
Registry, as well as clinical and refined SDOH information from the electronic health records system at the
University of Arkansas for Medical Sciences, will be utilized in this study. A longitudinal analysis for the
development of CV toxicities in women with a first diagnosis of BC (stage I–III), with passive follow-up in the
claims data through 2023, will be conducted. Machine-learning methods will be used to develop an algorithm
that predicts CV toxicities among BC survivors based on race, ethnicity, complex SDOH, and other clinical
factors. This K01 will: 1) provide training in social epidemiology and health disparities; 2) promote research
skills using large-scale, longitudinal administrative healthcare data; 3) develop competence in advanced
analytic methods; and 4) increase understanding of BC survivorship and provide content expertise in cardio-
oncology research. This study responds to the NHLBI's compelling question (5.CQ.10) to reduce cardiac
morbidity and mortality in cancer survivors. By identifying factors that contribute to health disparities in CVD
among BC survivors and using them to predict CV toxicity, this research can inform targeted interventions
(e.g., multidimensional intervention programs addressing race, ethnicity, and multiple SDOH) to improve the
CV health of this population.

Public health relevance
PROJECT NARRATIVE Cardiovascular (CV) toxicities from common cancer therapies (trastuzumab, anthracyclines, or left chest radiation) can lead to cardiovascular disease (heart failure, myocardial infarction, and stroke) and are more common among marginalized racial and ethnic groups, and those with adverse social determinants of health (SDOH) such as lower levels of socioeconomic status and living in disadvantaged neighborhoods or rural areas. Yet, the role of complex SDOH in CV toxicity disparities among breast cancer survivors is unknown, and few studies have considered the intersections among race, ethnicity, and other SDOH. This K01 aims to: 1) identify the extent of disparities in incident CV toxicity among breast cancer survivors in Arkansas based on race, ethnicity, neighborhood socioeconomic status, and geography; and 2) develop a predictive algorithm for risk stratification in breast cancer survivors at high risk for CV toxicity using machine-learning approaches that incorporate race, ethnicity, and SDOH to move beyond describing disparities in CV toxicities to informing targeted interventions to improve the CV health of breast cancer survivors.